MODULATION OF NEURONAL PLASTICITY IN THE HIPPOCAMPUS

Alzheimer's disease (AD) is characterized by excessive cell loss in the hippocampus and several of its afferent pathways, including inputs from the entorhinal cortex (EC), septum/diagonal band and locus coeruleus (LC). In response, the plastic properties of remaining neuronal populations have been reported to be either aberrant or absent, suggesting that the ability of the nervous system to respond to the disease process is impaired. However, the cellular mechanisms that underlie impaired neuronal adaptability in AD are unknown. The studies proposed will address this issue using experimental deafferentation lesions in rats to model the combination of neurotransmitter deficits typically found in AD and investigate the effect of multiple transmitter deficits on reactive synaptogenesis. In addition, we will determine the effect of aging on these processes. For our studies, we will test rats prior to surgery, using the Y maze, to identify subsets of mature (18mo.) and aged (24mo.) rats with hippocampal deficits that may alter their ability to respond to the lesion and the radial arm maze will be used to test rats at various time postlesion to correlate recovery of function with our morphological and molecular parameters. Morphological remodeling of surviving afferent fibers will be evaluated using light microscopic immunocytochemical and histochemical methods. In addition, we will use northern blot and in situ hybridization methods to identify changes in the prevalence of mRNAs of proteins that we hypothesize are associated with the trophic promotion of neurite outgrowth (BDNF), collateral or paraterminal axonal sprouting (GAP-43, SCG-10, P19, NF68), dendrite proliferation (MAP-2) and gap junction formation (Cnx 43 and 32). Data from our studies will provide information which is fundamental to understanding the sequence of morphological and molecular events that characterize reactive synaptogenesis in the dentate gyrus after deafferentation and the effect of aging on these processes. In addition, the information gained will provide insight into how the combined loss of glutamatergic, cholinergic and noradrenergic input to the hippocampus in AD may contribute to the pathophysiology of the disease process.